SAFETY AND EFFICACY OF ZDV FOR ASYMPTOMATIC HIV INFECTED INDIVIDUALS

This study evaluates the safety and efficacy of Zidovudine at two dosages compared to placebo in long term administration to HIV infected asymptomatic individuals.